Core--Clinical trial protocol review and monitoring system

Description: The Clinical Protocol Review and Monitoring Committee (CPRMC) consists of 22 members, appointed for three year terms, representing the major research and clinical disciplines of the VCC. The membership includes both M.D.s and non-M.D.s (e.g., investigators in the areas of biostatistics, preventive medicine, chemotherapy pharmacy, basic science, and nursing). Meetings are held twice a month as dictated by the number of submissions for review and a quorum must be present. The CPRMC reviews all protocols executed under the auspices of the Cancer Center and which use VCC resources.